CARDIAC LESIONS IN HIV1 TRANSGENIC MICE

DESCRIPTION (Adapted from applicant's abstract) The long term objective of this research proposal is to understand the cellular and molecular mechanisms of the cardiac lesions observed in HIV-1 transgenic mice that the applicants have recently constructed. In these mice, the HIV-1 gene products are expressed in cells which are the target of HIV-1 infection in humans, namely CD4+T cells and cells of the dendritic/macrophage lineage. The cardiac lesions are similar to those described in HIV-1-infected individuals. The investigators would like to understand the pathogenesis of these cardiac lesions and more specifically, intend; 1) To identify the HIV-1 gene product(s) responsible for this cardiac phenotype by constructing HIV-1 mutants; 2) To characterize changes in the pattern of gene expression in the heart of HIV-1 transgenic mice; 3) To identify the cells expression HIV-1 in the heart by in situ hybridization and immunocyto-chemistry; 4) To determine the contributions of each cell type (T lymphocytes and cells of the dendritic/macrophage lineage) to the development of cardiac lesions; 5) To determine whether the ablation of specific host genes (IL-6,TNF,R, iNOS, ICE) prevents the appearance of cardiac lesions; 6) To determine the role of monocytes/macrophages derived cytokines in cardiotoxicity using cocultures of normal of HIV-1 transgenic macrophages and cardiomyocytes; and 7) To determine whether apoptosis of cardiomyocytes is a major feature of cardiomyopathy observed in these mice. (End of Abstract)